Mitochondrial Membrane Dynamics in Th17 Cells

PROJECT SUMMARY
The extensive changes in phenotype and function observed in T cells upon activation are intimately linked to
changes in cellular metabolism. The failure to engage specific and appropriate metabolic programs can impair
or alter T cells, and thus lead to ineffective, or even overexuberant, immune responses. Central to metabolism
are mitochondria, which serve as central hubs of energy generation and biosynthetic activity. Work from our
group and others has provided mechanistic insights into how mitochondrial metabolism is critical to T cell
differentiation and function. However, knowledge about why these organelles change shape to maintain
metabolism, biosynthetic capacity, and function, and in what ways mitochondrial remodeling influences T cell
activation, differentiation, or effector molecule expression is lacking. Investigating how dynamic changes in
mitochondria regulate metabolism to impact CD4+ T cells will enhance our fundamental understanding of
immunobiology and of how to manipulate these cells for disease therapy in the context of cancer, infection, and
autoimmunity. In our initial experiments we found that unlike other Th cell subsets, Th17 cells, a cell type
necessary for maintaining gut homeostasis and implicated in certain types of autoimmunity and inflammation,
had elongated mitochondria in a fused network, as well as tight cristae morphology. These results suggested a
differential role for mitochondrial fusion and the protein OPA1, which mediates both membrane fusion and cristae
morphology, in these cells. OPA1 deletion had no discernible effect on Th1 and Th2 cell differentiation or cytokine
production in vitro, and while Th17 cell differentiation was also unimpaired, IL-17 expression was drastically
reduced. Further, mice with a T cell-specific OPA1 deletion were resistant to developing pathology in
experimental autoimmune encephalomyelitis (EAE), a Th17 cell-mediated autoimmune disease of the central
nervous system. Finally, our data revealed a role for liver kinase B1 (LKB1) in regulating the cellular response
to OPA1-deficiency, and in restraining Th17 cell IL-17 expression when mitochondrial fusion is perturbed. In this
proposal we now seek to understand how mitochondrial dynamics influence the function of diverse CD4+ T cell
subsets. Our overall goal is to dissect the function of OPA1 in Th17 cell effector function, as well as probe its
potential role other CD4+ T cell subsets, and to determine how MM fusion interfaces with LKB1 signaling to
modulate cellular metabolism to limit IL-17 expression in settings of mitochondrial disruption or stress in vitro
and in vivo. To this end, we propose to 1) explore the role of mitochondrial dynamics in CD4+ Th cells, 2)
determine the extent to which LKB1 controls the cellular response to OPA1-deficiency in Th17 cells, and 3)
investigate how metabolic changes upon disrupting mitochondrial fusion lead to dampened Th17 cell function.

Public health relevance
PROJECT NARRATIVE Th17 cells are critical for maintaining gut homeostasis, but are also implicated in certain types of autoimmunity and inflammation. This proposal’s objective is to understand the cellular metabolic pathways in Th17 cells and how changes in mitochondria, the so-called powerhouse of the cell, impact Th17 cell function, as well as function in other T cell subsets. Defining the mechanisms that regulate T cell metabolism will be critical for gaining new insights into how to therapeutically target these cells in the context of autoimmune disease, infection, and cancer.